Daily & Localized NSAID Sonophoresis for Symptomatic Treatment of Knee Osteoarthritis

Project Summary:
Arthritis is a significant economic and health burden in the United States which is estimated to exceed $394
billion in healthcare costs by 2030. Osteoarthritis (OA) is the most common type of arthritis, affecting over 32
million adults in the United States and represents over 25% of medical office visits according to the Centers for
Disease Control and Prevention and the National Institutes of Health. Over 40% of individuals over 65 have
symptomatic OA and reduced mobility due to the disease. OA pain is often mitigated with conservative treatment
approaches such as water therapy, walking, cycling, and pharmaceuticals. Regular use of NSAIDs can have
adverse side effects on cardiovascular, gastrointestinal and renal systems. As such, topical NSAIDs and intra-
articular corticosteroids are often used to provide localized pain relief for patients. However, neither of these
therapeutic approaches provide pain relief without risks including skin irritation, infection and accelerated loss of
cartilage. Long-duration ultrasound has been used to reduce pain and improve joint function in patients with knee
OA. When ultrasound is used in conjunction with topical pharmaceuticals, sonophoresis drives the molecules
deeper into tissue, providing improved pain relief compared to ultrasound or topical application of NSAIDs alone.
In our SBIR Phase I/II project, we developed a novel diclofenac sonophoresis patch for the management of knee
OA. We demonstrated that the sonophoresis technology could increase tissue penetration of NSAIDs by 3.8x
compared to standard of care (p<0.01) and exhibit an excellent safety profile. We completed regulatory testing
including sensitization, cytotoxicity, packaging/formulation stability, biocompatibility, microbial growth, shelf-life
and home-use application of the sonophoresis patch. We also completed a human-factors study, clinical
diathermy study and two knee OA clinical studies on patients with radiographically confirmed mild to moderate
knee OA. The sonophoresis patch reduced knee pain by up to 2.96 points after 1-week (p<0.001) and by 3.43
points after 8-weeks (p<0.0001) of daily use; significantly more than topical diclofenac arthritis medication alone.
Over 98% of study participants found the device easy to use and would continue treatment for their knee OA
symptoms. For this SBIR Phase IIB renewal we (1) complete 3-year validation testing of the device to meet all
remaining federal requirements for the sonophoresis patch, and (2) complete a 12-week, 3-arm, multi-site,
placebo-controlled, randomized, clinical superiority study to expand upon our Phase I/II results and demonstrate
the combined benefit of multi-hour ultrasound + diclofenac in reducing pain, improving mobility and quality of life
for patients with knee OA. The overarching goal of this SBIR program is to bring a non-invasive, non-opioid,
targeted, clinically superior, easy-to-use, knee OA treatment option to the aging patient population regardless of
ethnicity, socioeconomic status, or geographical barriers to healthcare.

Public health relevance
Project Narrative: This SBIR Phase IIB project continues development of the first home-use NSAID-enhanced sonophoresis patch for use by the active aging population with knee Osteoarthritis. The innovative treatment has been evaluated in laboratory, clinical-research and real-world settings demonstrating superior efficacy to reduce pain and restore function. We will now complete remaining regulatory requirements for servicing the diverse aging population, establish coding and policy for the technology to provide broader access to the treatment, and demonstrate a clear clinical advantage over standardized intra-articular corticosteroid injections in the symptomatic management of knee Osteoarthritis.